Regulation of Mitochondrial Respiration in Diabetic Kidney Disease

PROJECT SUMMARY
Current treatments of diabetic kidney disease (DKD) mainly focus on managing the symptoms of diabetes and
do not address the root causes of DKD. Among causal mechanisms associated with the progression of DKD,
there is growing recognition of the central role of mitochondrial dysfunction. Importantly, various aspects of
mitochondrial function in kidney cells are known to be impaired in experimental models and in individuals with
DKD, including enhanced generation of reactive oxygen species (ROS), substantial alterations in mitochondrial
dynamics and structure, and mitochondrial electron transport chain dysfunction.
Dysregulated mitochondrial electron transport chain (ETC) has recently emerged as a leading cause of
mitochondrial dysfunction in DKD, contributing to the progression of DKD and other micro/macrovascular
complications of diabetes. However, the nature or ETC dysfunction in the development of DKD remains
unknown. This proposal is based on our recent observations (Mise K. et al. Nature Commu 2024), indicating
that: (1) the expression of Ndufs4 (NADH: ubiquinone oxidoreductase iron-sulfur protein 4), a subunit of the
complex I of the ETC, is consistently reduced in kidney podocytes of diabetic mice; (2) conditional overexpression
of Ndufs4 in the podocytes of diabetic mice (Ndufs4podTg) restored ETC function and improved mitochondrial
dynamics and structure in podocytes; and (3) diabetic mice with Ndufs4podTg exhibit significant improvement in
albuminuria and kidney morphology compared to control DKD mice. Overall, these discoveries highlight the role
of ETC remodeling under diabetic conditions. However, several key questions remain to be carefully addressed,
including, a) is mitochondrial ETC regulated in DKD? and if so, how? b) can we unbiasedly identify novel
regulators of ETC remodeling in DKD? and c) what are the molecular mechanisms and physiological
consequences of altered ETC regulators in DKD? In this application, we propose to address these questions
by designing an unbiased genome-wide single-cell CRISPR (clustered regularly interspaced short
palindromic repeats) platform to identify and validate regulatory genes that affect mitochondrial ETC
fitness in DKD. As a proof of principle, we recently conducted a pooled genome-wide CRISPR interference
(CRISPRi) screen using a mouse sgRNA library and a mitochondrial ROS sensitive reporter (mito-roGFP2) in
Ndufs4 deficient (Ndufs4+/-) vs. Ndufs4+/+ wild type cultured podocytes. We identified a subset of genes that are
involved in mROS generation in a Ndufs4-dependent manner in podocytes. We now propose under three well-
defined Specific Aims to identify and dissect the molecular mechanisms of action of putative regulators of Ndufs4-
mediated ETC dysfunction. We believe that the successful completion of this application will not only fill the
knowledge gap on regulators of ETC but will also provide foundational insights into the pathogenesis of DKD.
Developing novel strategies based on restoring ETC activity in DKD could be a promising approach toward
correcting kidney cells energetics which represents a paradigm shift in the management of DKD patients.

Public health relevance
Project Narrative Mitochondria are increasingly emerging as critical hubs for integrating intracellular signaling, biosynthetic and bioenergetic activities of the cell. In this application, we will address how the electron transport chain (ETC) of mitochondria is regulated in podocytes and whether dysregulated ETC fitness contributes to the development and progression of diabetic kidney disease (DKD). The completion of this project will define the central role of ETC as a targetable therapy for progression of DKD.